Integrative Omics analysis of human cartilage in aging and osteoarthritis

ABSTRACT
Osteoarthritis (OA) is the most prevalent joint disease. Although many drug targets have been identified that
were successful in preclinical studies, clinical trials on disease modifying OA drugs thus far have failed and
pain management remains unsatisfactory. Approaches such as testing disease-related differences in
expression of selected genes or proteins and analyzing their function in preclinical models has yielded a large
number of pathways and molecules that are abnormal in OA. The limitations of these approaches are (i) that
they provide only a selective view of molecular changes in OA and (ii) there has been no successful effort in
integrating these findings into networks and prioritizing targets by their relevance as drivers of the OA process.
This project leverages (i) our access to and expertise in working with human knee tissues from donors across
the entire adult age spectrum and at all stages of OA development; (ii) existing and growing human knee tissue
libraries; (iii) technical advances in genome wide analyses of transcriptomic changes, which provide an
unbiased and comprehensive view of the genetic landscape of cartilage homeostasis and OA; (iv) our
expertise in developing pipelines for integrative network analysis of multi-Omics data sets.
Our hypothesis is that dysregulation transcription factors (TFs) is a major determinant of the abnormal gene
expression pattern that drives OA pathogenesis. Our approach is to generate data from gene expression
(mRNAseq) and enhancer activation analysis (GRO-seq) at the tissue level and more precisely at the single
cell level to identify novel signatures, pathways and key regulators of cartilage homeostasis and OA.
Aim 1. The transcriptomic landscape of normal and OA human articular cartilage single cell levels. We will
perform single-cell RNAseq to identify chondrocyte subpopulations in normal and OA human articular
cartilage.
Aim 2. Enhancer profiling to identify drivers of pathogenic gene expression patterns in OA. Active enhancers
are characterized by the presence of enhancer RNAs (eRNAs). We will use GRO-seq to assay eRNA
transcription in normal and OA chondrocytes. These results will reveal pathways and networks that are
disrupted in OA and identify principal regulators of OA pathogenesis.
Aim 3. Validation: Confirm differences in TF expression and activation in joint tissues and analyze function in
joint tissue cells. We will assess differences in TF protein expression and activity in cartilage and other joint
tissues and determine the role of candidate TFs in mediating expression of OA-associated gene patterns.
Impact: To our knowledge, this is the first project to examine genome-wide mRNA expression profiles in
healthy and OA-affected knee cartilage at tissue and single cell levels and linking this transcriptomic data with
analysis of TF expression and activity. The study has potential discover novel pathways and principal
molecular switches as therapeutic targets. Ultimately this may lead to interventions to delay or treat OA.

Public health relevance
PROJECT NARRATIVE Osteoarthritis affects members of almost every family in the United States. This project will examine gene expression patterns at tissue and single cell levels and regulatory mechanisms that characterize cartilage homeostasis and osteoarthritis in human knees. Data and insight generated from this proposal will provide new and important insights into the pathobiology and osteoarthritis, lead to new biomarkers, and identify more promising targets for therapeutic interventions to prevent or treat osteoarthritis.